Sp4 Pathway in the Modulation of Sensorimotor Gating and Memory

DESCRIPTION (provided by applicant): Animal models based on genetic manipulations can contribute enormously to our understanding of diseases of the brain. Mutant mice with reduced expression of the Sp4 transcription factor display deficits in sensorimotor gating and contextual learning that resemble putative endophenotypes for schizophrenia. The Sp4 gene is significantly associated with schizophrenia and bipolar disorder. In mouse studies, reduced expression of the Sp4 gene impaired long-term potentiation (LTP) in hippocampal CA1, impaired spatial learning, and markedly decreased the expression of NMDAR1, the core subunit for NMDA glutamate receptors. Impaired NMDA function plays a central role in the pathophysiology of schizophrenia. This identification of a novel Sp4-NMDAR1 pathway provides a basis for cross-species studies related to human psychiatric disorders. This renewal application investigates how Sp4 regulates expression of NMDAR1 proteins to modulate neural pathways involved in sensorimotor gating and cognitive functions. The central hypotheses are that Sp4 post-transcriptionally regulates the expression of NMDAR1 and that restoration of Sp4-NMDAR1 expression in specific brain regions will reverse both sensorimotor gating and cognitive deficits in Sp4 hypomorphic mice. Four Specific Aims will test these hypotheses: Aim 1: To elucidate molecular mechanisms for differential expression of NMDAR1 proteins between wildtype and Sp4 hypomorphic mice. The localization of NMDAR1 mRNA will be examined by in situ hybridization. The differential translation and turnover of NMDAR1 proteins will be examined using TimeSTAMP2.2-Venus tag. Aim 2: To reverse deficient sensorimotor gating by restoring Sp4-NMDAR1 expression in excitatory and inhibitory neurons respectively. The expression of Sp4-NMDAR1 will be restored in excitatory and inhibitory neurons of both neocortex and hippocampus, to reverse prepulse inhibition gating deficits in Sp4 hypomorphic mice. Molecular and pharmacological studies will further characterize the conditional rescued mice. Aim 3: To determine whether Sp4 hypomorphic mice exhibit cognitive deficits modulated by the frontal cortex, and whether restoration of Sp4-NR1 expression in frontal cortex will reverse these deficits. Both the Attentional-Set-Shifting Task and the Odor Span Task will be used to examine cognitive functions in Sp4 hypomorphic and conditional rescued mice. Aim 4: To test whether restoration of Sp4 expression in hippocampal CA1 is sufficient to reverse the LTP and spatial learning deficits in Sp4 hypomorphs. Sp4- NMDAR1 expression will be restored in CA1 by crossing CamK2a-Cre and Sp4 hypomorphic mice. The formation and consolidation of spatial and contextual memories will be examined in the Sp4 hypomorphic mice harboring CamK2a-Cre. The proposed studies will help elucidate molecular mechanisms underlying the modulation of sensorimotor gating and learning, and aid the development of clinical interventions to prevent the down-regulation of Sp4-NMDAR1 pathway in human psychiatric disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Sp4 gene, which has recently been associated with both schizophrenia and bipolar disorder, codes for an important transcription factor in brain cells that regulates the function of glutamatergic receptors involved in the cognitive impairments in psychiatric disorders. This project seeks to use animal models to elucidate molecular mechanisms related to specific cognitive abnormalities in schizophrenia, in order to aid the development of clinical interventions to prevent the dysregulation of the Sp4-glutamate pathway in human psychiatric disorders. Project Narrative The Sp4 gene, which has recently been associated with both schizophrenia and bipolar disorder, codes for an important transcription factor in brain cells that regulates the function of glutamatergic receptors involved in the cognitive impairments in psychiatric disorders. This project seeks to use animal models to elucidate molecular mechanisms related to specific cognitive abnormalities in schizophrenia, in order to aid the development of clinical interventions to prevent the dysregulation of the Sp4-glutamate pathway in human psychiatric disorders. __SpecificAimsTextDelimiter__ 2. STATEMENT OF HYPOTHESIS AND SPECIFIC AIMS Animal models based on genetic manipulations can contribute enormously to our understanding of diseases of the brain. Although it is nearly impossible to fully model psychiatric syndromes in animals, the use of cross- species measures to probe molecular and neural pathways affected in psychiatric disorders represents a fruitful approach to understand the substrates of human psychiatric disorders (Carpenter & Koenig 2008; Geyer, 2002; Gogos and Karayiorgou, 2001). Our previous work demonstrated that hypomorphic Sp4 mutant mice display deficits in sensorimotor gating and contextual memory (Zhou et al., 2005). The complete absence of Sp4 resulted in an impaired postnatal development of hippocampal dentate gyrus (Zhou et al., 2007). Deficits in sensorimotor gating and learning/memory have been proposed as putative endophenotypes for schizophrenia and other psychiatric disorders (Braff et al., 2001; Dempster et al., 2006; Wittorf et al., 2004). Recently, we found that reduced expression of the Sp4 gene impaired the generation of long-term potentiation (LTP) in the hippocampal CA1 and led to associated deficits in spatial learning in Sp4 hypomorphic mice. Molecular studies further revealed that reduced Sp4 expression markedly decreased the expression of NMDAR1 (NR1), the core subunit for all NMDA receptor channels, throughout the mouse brain (Zhou et al., in review). Impaired NMDA neurotransmission plays a central role in the pathophysiology of schizophrenia and other psychiatric disorders (Lee et al., 2005; Carlsson et al., 1997; Javitt and Zukin, 1991; Kristiansen et al., 2007; Krystal et al., 1994; Lahti et al., 1995; Malhotra et al., 1997; Olney et al., 1999). For example, recent studies show that all patients with anti-NMDA-receptor (anti-NR1) encephalitis developed schizophrenia-like symptoms and/or memory deficits (Dalmau et al., 2008; Iizuka et al., 2008). Three independent human genetic studies, including the finding of sporadic SP4 deletions in schizophrenia patients, indicate that SP4 functions as a susceptibility gene for both schizophrenia and bipolar disorder (see Progress Report). Therefore, the identification of the novel Sp4-NMDAR1 pathway provides a solid foundation for cross-species studies to further our understanding of human psychiatric disorders. In this competitive renewal application, we propose to investigate neural pathways involved in the modulation of both sensorimotor gating and cognitive functions, and determine how Sp4 regulates the expression of NMDAR1 proteins. We hypothesize that Sp4 post- transcriptionally regulates the expression of NMDAR1 and that restoration of Sp4-NMDAR1 expression in specific brain regions of Sp4 hypomorphic mice will reverse both cognitive and sensorimotor gating deficits. To examine these hypotheses, we propose the following Specific Aims: Specific Aim 1: To elucidate molecular mechanisms for differential expression of NMDAR1 proteins between wildtype and Sp4 hypomorphic mice. The localization of NMDAR1 mRNA will first be examined by RNA in situ hybridization in the brains of both WT and Sp4 hypomorphic mice. The differential translation and/or turnover of NMDAR1 proteins will be examined by using TimeSTAMP2.2-Venus tag. Specific Aim 2: To reverse deficient sensorimotor gating by restoring Sp4-NMDAR1 expression in excitatory and inhibitory neurons respectively. The expression of Sp4-NMDAR1 will be restored in excitatory and inhibitory neurons of both neocortex and hippocampus respectively, to reverse sensorimotor gating (i.e. prepulse inhibition of startle) deficits in Sp4 hypomorphic mice. Molecular and pharmacological studies will be conducted to further characterize the conditional rescued mice. Specific Aim 3: To determine whether Sp4 hypomorphic mice exhibit cognitive deficits modulated by the frontal cortex, and whether restoration of Sp4-NMDAR1 expression in the frontal cortex will be sufficient to reverse the cognitive deficits. Both the Attentional-Set-Shifting Task (ASST) and the Odor Span Task (OST) will be used to examine executive functioning and 'working memory' respectively of Sp4 hypomorphic mice and the conditional rescued mice from Aim 2. Specific Aim 4: To assess whether restoration of Sp4 expression in hippocampal CA1 is sufficient to reverse the spatial learning deficit in Sp4 hypomorphic mice. The Sp4-NMDAR1 expression will be restored in hippocampal CA1 by CamK2a-Cre mice in Sp4 hypomorphic mice. The formation and consolidation of both spatial and contextual memories will be examined in the Sp4 hypomorphic mice harboring CamK2a-Cre. Abbreviation Key: ID......Intradimensional PPI.......prepulse inhibition AAV.....Adeno-Associated Virus ASST...Attentional Set Shifting Task COGS. Consortium on the Genetics of Schizophrenia ED........Extradimensional OST......Odor Span Task LTP...Long-Term Potentiation NMDAR..NMDA Receptor NR1.......NMDAR Subunit 1 PCP......phencyclidine UCSD....Univ. California San Diego WT........wildtype YFP......Yellow Fluorescent Protein